Tracking the evolution of synaptic dysplasticity after early life seizures

PROJECT SUMMARY
Multiple lines of clinical and experimental evidence suggest that seizures in early life can be
associated with long lasting cognitive and behavioral deficits. In rodent models, we have showed that early
life seizures (ELS) impair normal synaptic plasticity, critical period plasticity, later life learning and social
behavioral deficits. Improved understanding as to how seizure activity and hyperexcitable networks
dysregulate synaptic plasticity will be required to develop new therapeutic strategies in this clinical space
where no current cure exists.
We will focus on dysplasticity related to alterations of the excitatory synaptic glutamate receptor and
its related signaling pathways. Tracking alterations of synaptic glutamate receptors in neurons activated by
ELS is a specific challenge given that they occur in the midst of the synaptic critical period, the refinement of
synaptic connections and the dispersion of neurons with development, which makes it difficult to localize
neurons for functional studies later in life, despite the persistence of impaired synaptic plasticity and
cognitive deficits. Similarly, sampling of a neuronal population for gene and protein expression may fail to
show alterations occurring in a small, critical, subset of cells. To address these issues, we have adapted a
method to permanently label cells activated by ELS in mice so that we can measure synaptic responses,
gene and protein expression at a single neuron level, and then differentially label them during subsequent
later life seizure (LLS) events. Using our ELS models, we aim to determine whether neurons activated by
ELS have persistent, life-long, alterations of glutamate receptor function associated with impaired synaptic
plasticity and hyperexcitability compared to neurons from no-seizure control mice (Aim 1). We will correlate
these functional changes with measurements of gene and protein expression related to glutamate receptor
function compared to neurons from no-seizure control mice (Aim 2). Finally, we will determine whether
neurons activated by ELS are differentially affected by a second later life seizure (LLS) in adulthood
compared to control neurons in seizure free mice (Aim 3). The synapse is a convergence point for the
likely many upstream derangements of network function, and therefore an ideal target of study. We
hypothesize that tracking the evolution of changes over time in select neuronal populations following ELS will
allow us to both “stage” the evolution of changes and identify new therapeutic targets for this comorbidity and
consequence of seizures in the immature brain.

Public health relevance
PROJECT NARRATIVE Seizures in early life occur in the setting of epilepsy, autism and other neurodevelopmental disorders and emerging evidence suggests that they play a role in later impairments in learning and behavior. This proposal will use a new mouse model to “track” brain cells affected by seizures in early life over time in order to learn how they are altered, with the goal of identifying new therapeutic targets to prevent these negative consequences of early life seizures.